CRYSTAL STRUCTURE OF MOLECULAR CHAPERONE

Molecular chaperones play key roles in protein folding, transport across membranes, and in response to stressful stimuli. We have recently succeeded in overexpressing, purifying and crystallizing Hsc20, a J-motif co-chaperone protein which regulates the chaperone Hsc66 in E. coli. A native data set to 1.9 E resolution has been collected, and heavy atom derivatives are now being characterized in order to solve the structure by multiple isomorphous replacement methods.